Career Enhancement Program

CAREER ENHANCEMENT PROGRAM: SUMMARY
The Northwestern Brain Tumor SPORE (NBTS) Career Enhancement Program (CEP) is responsible for
recruitment and training of new and early stage investigators committed to neuro-oncology research to ensure
that there will be a continuous source of talented investigators committed to this field. The fact that the faculty
mentors come from a variety of departments and disciplines provides a source of diversity and scientific
expertise to program awardees. CEP recipients are selected after wide solicitation of the request for
applications and careful review of applicants' credentials and potential to develop an independent career in
brain tumor research. The CEP leadership, Drs. James and Lesniak, will make special efforts to emphasize
the recruitment of women and minorities to the SPORE CEP, both at the levels of award recipients and
mentors.
The CEP has flexibility in terms of offering awards and the length of the award. However, there is a consistent
and highly-structured process for solicitation and selection of CEP investigators and a detailed tracking system
for monitoring their progress. The specific aims of the CEP are:
Specific Aim 1. To maintain an administrative structure for the Career Enhancement Program.
Specific Aim 2. To solicit and select career enhancement investigators through a highly structured process.
Specific Aim 3. To mentor and continuously evaluate career enhancement investigators through individual
meetings with mentors, bi-annual presentations at SPORE investigator work in progress meetings and written
progress reports.
Specific Aim 4. To cultivate new faculty to embark on careers in neuro-oncology to ensure a future source of
talented investigators committed to brain cancer research.

Public health relevance
CAREER ENHANCEMENT PROGRAM: PROJECT NARRATIVE The Career Enhancement Program is a critical component of the Northwestern Brain Tumor SPORE, in that it ensures that there will be a continuous influx of talented investigators devoted to brain cancer research.